SPORE for Translational Approaches to Brain Cancer

OVERVIEW: SUMMARY
The overall objective of the Northwestern Brain Tumor SPORE is to improve outcomes for brain tumor
patients. Statistics on brain tumor incidence indicate that more than 23,000 people will be diagnosed with a
brain tumor in the U.S. in 2017, and approximately 17,000 will succumb to their disease. Of the various primary
intracerebral neoplasms, glioblastoma (GBM) is the most common. GBM patients that receive standard-of-care
treatment have a median survival of 15 months, and 5-year survival is extremely rare. Progress in developing
better treatments for this lethal tumor has been disappointing. A major contributor to this lack of therapeutic
improvement is the delicate nature of the organ in which this cancer occurs. There are significant limitations to
how aggressively GBM patients can be treated surgically, and the efficacy of systemically administered
therapies are often compromised due to limited access to the brain. To address the public health problem that
is associated with glioblastoma, we have assembled a talented team of investigators with extensive
backgrounds in brain tumor research and therapy. All members of this team have professional records
indicating success in directing their own programs of research. Some 3+ years ago, these faculty initiated
group interactions in order to bring a team science approach to bear upon the study and treatment of GBM,
and for which a multidisciplinary approach is needed for achieving meaningful progress.

Public health relevance
OVERVIEW: NARRATIVE The Northwestern Brain Tumor SPORE is for improving treatment outcomes for patients afflicted with highly malignant primary brain tumors, with particular emphasis on glioblastoma. This goal will be accomplished through the efforts of a talented group of investigators that will combine complementary expertise in a team science approach leading to meaningful progress in effectively treating tumors that currently have a dismal prognosis.